The Role of eIF4G1 and eIF4G2 in Translational Control of Adipogenesis and Obesity

PROJECT SUMMARY
Obesity, a disease caused by elevated fat mass, has increased in prevalence over the past few decades.
Over 30% of the population suffers from obesity, and over time it can lead to increased incidence of life-
threatening pathologies, including Type II Diabetes, heart disease, and cancer. Much study has been devoted
to finding new treatments, which remain ineffective because 1) obesity is highly polygenic, and 2) they ameliorate
symptoms rather than target the disease source. It is urgent to identify pathways disrupted in obesity to develop
better therapeutics that more precisely treat the case-specific source of fat mass expansion.
My lab contributed to this effort by performing a genome-wide screen for fat mass-regulating GPCRs and
discovered FFAR4, a ciliary GPCR that binds ω-3 fatty acids to promote preadipocyte differentiation into new
adipocytes (adipogenesis) instead of depositing lipids in existing tissue, causing inflammation (hypertrophy).
This discovery is especially useful to human health because even though adipogenesis and hypertrophy both
cause weight gain, hypertrophy is ultimately much more pernicious because the chronic inflammation leads to
complications, including hypertension and diabetes. Therefore, understanding how FFAR4 drives preadipocyte
differentiation may help us circumvent hypertrophic obesity and downstream pathology. The mechanism by
which FFAR4 drives adipogenesis has yet to be elucidated. To do so, the Jackson lab performed the first
genome-wide CRISPR knockout screen for FFAR4-pathway adipogenesis regulators using preadipocytes
harvested at different time points post-differentiation. Our lab discovered that translation initiation factors eIF4G1
and eIF4G2, highly homologous proteins that compete for the same ribosomal binding site to drive transcript
recruitment, have opposite effects on adipogenesis downstream of FFAR4: eIF4G2 was the strongest inhibitor
and eIF4G1 was one of the strongest drivers of adipogenesis. I will test my central hypothesis that the switch
from eIF4G2-dependent to eIF4G1-dependent translation (by degradation of eIF4G2 and activation of eIF4G1),
downstream of FFAR4-induced cAMP signaling, drives fate change through converting to the translation of
transcripts that specifically promote adipogenesis. I will use a combination of 3T3-L1 preadipocytes and mouse
genetic models to gain mechanistic insight into eIF4G1/2 functions on a cellular and systemic level. In Aim 1, I
will determine the mechanism of eIF4G1/2 function in preadipocyte differentiation in vitro. I will tease apart the
pathway(s) through which eIF4G1 and eIF4G2 act by probing mechanism, tracking their kinetics in adipogenesis,
determining if they are necessary/sufficient to drive adipogenesis, and identifying the transcripts they each
regulate. In Aim 2, I will determine the role of eIF4G1/2 in fat expansion and metabolism in vivo using mouse
model systems to see how eIF4G1 and eIF4G2 function relates to multicellular systems. Taken together, my
work will pave the way for exploring the network of signaling events that drive adipogenesis downstream of the
cilium and may pave the way for therapeutics targeting monogenic sources of obesity.

Public health relevance
PROJECT NARRATIVE Obesity, or elevated fat mass, is a severe pathology that has increased in prevalence in the past few decades and has close links to life-threatening diseases including hypertension, heart disease, Type II Diabetes Mellitus, and even cancer. Recent studies have revealed that obesity can arise due to disruption of a number of different genes, making there an urgent need to understand the numerous pathways that drive obesity to allow for the development of therapeutics that more precisely target the disease source. The goal of this study is to explore the function of the translation initiation factors eIF4G1 and eIF4G2 as novel regulators of fat cell proliferation and how disruption of the switch from eIF4G2 to eIF4G1-mediated translational control propagates disease.